Evaluating Social Connectedness to Support Recovery from Opioid Use Disorder during the Postpartum Period

PROJECT SUMMARY
The prevalence of opioid use disorder (OUD) during pregnancy has increased by nearly 500% over the past 15
years. While motivation for and compliance with OUD treatment during pregnancy is heightened, up to 80% of
postpartum individuals with OUD relapse to illicit opioid use within six months of childbirth. A growing body of
evidence indicates that, in the general population, positive social connectedness and strong social bonds are
associated with improved OUD recovery outcomes (e.g., reduced craving, lower risk of relapse). Conversely,
loneliness and social isolation are significant predictors of opioid misuse and relapse, particularly for women.
Loneliness increases during transitional periods including from pregnancy to postpartum, signaling increased
risk for adverse recovery outcomes. Moreover, relapse risk during the fourth trimester (i.e., the time from delivery
to postpartum week 12) may be compounded by unique postpartum stressors, including postpartum depression
and anxiety, sleep disturbances, heightened need for pain management, and caregiving-specific stress. Our
overall goal is to understand the role of social connectedness in OUD-related recovery outcomes, specifically
during the postpartum fourth trimester, an ideal inflection point with untapped potential. To achieve this goal we
will pursue three aims. The first two aims will utilize existing data (derived from DP2-HD105541; PI: Allen) from
50 participants with OUD and 25 control participants who were followed from pregnancy through five months
postpartum. Using ecological momentary assessments (EMA) paired with medical record data, we will assess
social connectedness and OUD-related recovery outcomes. We will evaluate differing theoretical models of
social connectedness in this population by testing the main and stress-buffering effects of social connectedness
on recovery outcomes up to one year postpartum (Aim 1). Additionally, we will characterize dynamic changes in
social connectedness across the fourth trimester and how patterns/changes relate to mothers’ recovery
outcomes (Aim 2). Lastly, we will complete key informant interviews with 30 participants from the target
population to explore the feasibility, acceptability, and opportunities for intervention to enhance social
connectedness to improve the treatment of OUD and prevent postpartum relapse (Aim 3). The results of this
study, regardless of outcome, will directly contribute to scientific knowledge on the role of social connectedness
in postpartum OUD recovery. Moreover, this work will allow for the identification of new intervention targets,
which will contribute to the development of novel, high-impact relapse prevention treatments tailored to the fourth
trimester, a unique inflection point with ample untapped opportunity. This will be directly impactful to the 80,000-
120,000 women, infants, and families suffer the consequences of perinatal OUD every year.

Public health relevance
PROJECT NARRATIVE Our overall goal of this project is to understand the role of social connection OUD-related recovery outcomes, specifically during the postpartum period. The results of this study, regardless of outcome, will directly contribute to scientific knowledge on the role of social connectedness in postpartum OUD recovery. Moreover, this work will allow for the identification of new intervention targets, which will contribute to the development of novel, high- impact relapse prevention treatments tailored to the perinatal period, a unique inflection point with ample untapped opportunity.